National Center for Quantitative Biology of Complex Systems

PROJECT SUMMARY – ADMINISTRATION AND MANAGEMENT
Our administrative infrastructure has been molded to meet the needs of the NCQBCS as it stands today. All Co-
Investigators have been recruited by Resource PI Coon to fulfill the scientific and technical needs of the
Resource. Co-Investigators Pagliarini and Li, both part of Cycle 1, will continue their commitment to the
NCQBCS’s work. Our TR&Ds and DBPs have been organized to take advantage of the expertise of the
investigators. Dr. Pagliarini, with assistance from Dr. Katie Overymyer, will continue to lead the DBPs. Pagliarini
has an extensive background in chemical and molecular biology. Overmyer is a classically trained biochemist
who has recently joined our staff. Prof. Li is recognized as a leader in chemical labeling strategies for quantitative
proteomics using mass spectrometry and is therefore a natural fit for TR&D 2, which focuses on developing
enhanced tagging technologies for protein quantification. In Cycle 2, we are excited to announce that we will be
bringing in Prof. Robert Kennedy, University of Michigan, to provide cutting-edge separations technology needed
to advance the multi-omics component of our scientific aims. Therefore, our established procedures will be
modified to ensure proper integration of an off-sight Co-Investigator into the Resource. Prof. Kennedy’s expertise
makes him the ideal lead for TR&D 3, directed toward integrated multi-omics. PI Coon brings extensive
experience in instrumentation, training, and leadership, making him the perfect fit as the PI of the Resource and
lead of TR&D 1 on biomolecule characterization. Although each investigator has responsibility for direction and
lead on an individual component, no TR&D or DBP can be successfully carried out on their own. They are neither
disparate projects nor research interests that simply happen to fall under the same thematic umbrella. In fact,
they are by design integrative with collaborative interaction between the Co-I’s across the TR&D projects.
Figure 3. NCQBCS organizational chart. Note this is
structure is largely unchanged from Cycle 1.